MULTIDISCIPLINED ANALYSIS OF CHEMOPREVENTIVE AGENTS

The objective of this particular acquisition is to evaluate and analyze data on inhibitors or potential inhibitors of any stage of carcinogenesis in order to establish a prioritization of candidate chemopreventive agents.